Postpartum Neurobiological Sequelae of Prescription Opioid Use During Pregnancy

PROJECT SUMMARY
Pregnancy is a critical period for brain development, and drug use during this time disrupts ontogenic trajectories.
During the last decade, the use of prescription opioids during pregnancy has reached notably high rates (14-
22%) in the United States. While previous research has focused on the offspring for in utero effects of opioid
use, the impact on the mother’s postpartum mental health has been largely overlooked. Notably, drug overdoses
are one of the main preventable causes of pregnancy-related deaths, mainly occurring in this period. Here, we
will assess the neurobehavioral changes caused by prescription opioid exposure during pregnancy and their
postpartum impact on drug reward. The proposed work will focus on two key at-risk mechanisms during
pregnancy: oxytocin and dopamine. Central oxytocin signaling by paraventricular hypothalamic neurons
(PVNOXT) is halted during pregnancy and quickly re-initiated after parturition. Upon resumption of oxytocin
release, ventral tegmental area (VTA)-projecting PVNOXT neurons promote attribution of incentive value to salient
stimuli (e.g., pups). Therefore, VTA-projecting PVNOXT, which express µ-opioid receptors (µOR), represent a
substrate for the pharmacological actions of prescription opioids (such as oxycodone) during pregnancy. We
hypothesize that repeated activation of PVNOXT µOR leads to opioid tolerance and a long-term loss of inhibitory
control over PVNOXT excitability, hence exacerbating VTA oxytocin release and altering dopamine function
postpartum. We will use drug self-administration and neuroeconomic modeling to profile postpartum vulnerability
to drug abuse in dams exposed to prescription opioids during pregnancy. Additionally, we will employ fiber
photometry to examine in vivo changes in dopamine and oxytocin encoding of opioid rewards and
electrophysiological tools to characterize PVNOXT synaptic alterations. Finally, optogenetic manipulations will
address the sufficiency of the PVNOXT→VTA pathway to gate augmented postpartum reward-seeking behaviors
in opioid-naïve mice. Together, these experiments will uncover novel behavioral and neural circuit aberrations
resulting from prescription opioid exposure during pregnancy, focusing on the dam’s vulnerability to postpartum
opioid abuse. Ultimately, this research proposal seeks to uncover a potential neurobiological mechanism linking
the increased use of prescription opioids during pregnancy and the rise in postpartum overdose deaths.

Public health relevance
PROJECT NARRATIVE The current proposal examines how exposure to prescription opioids during pregnancy affects postpartum mental health and motivation for drug rewards. Oxytocin and dopamine signaling interactions are an at-risk substrate for the pharmacological actions of opioids during pregnancy. Using a combination of behavioral, neuroeconomic, optogenetic, and electrophysiological methods, this project seeks to reveal a causal link between prescription opioid use during pregnancy and postpartum opioid abuse risk, one of the main preventable causes of pregnancy-related deaths in the United States.